GESTATIONAL DIABETES MELLITUS SCREENING

The purpose of this study is to obtain the results of all one hour blood sugar screens done over two years. To identify all abnormal values (at or over 140 mg/dl). Obtain results of the OGTT done for each of the abnormal screening tests, and evaluate results to attempt to find a value over which the OGTT is consistently abnormal. CDMAS ONLY.